"Enhancing Cancer Research in Central Africa IeDEA"

Title: Barriers and facilitators of cancer care and financial burden of cancer care in Kinshasa, the
Democratic Republic of the Congo
ABSTRACT
Growing cancer morbidity and mortality is a major public health problem globally, which disproportionality
affects low- and middle-income countries. In sub-Saharan Africa, cancer incidence has doubled in the past
30 years. Most cancer patients in SSA present at an advanced stage of disease, impacting prognosis and
survival, which may be attributed to significant barriers to access care. HIV and cancer comorbidity is
significant and people living with HIV are less likely to access cancer care. High poverty rates in SSA
countries exacerbate multiple barriers to HIV and cancer care. In most countries, cancer management is
not included in the core health services and most cancer care expenses are paid for out of pocket. To
better understand barriers to and facilitators of cancer care in the Democratic Republic of Congo (DRC),
financial burden of cancer care and its impact, we leverage the Central Africa International Epidemiology
databases to Evaluate AIDS infrastructures and the ongoing collaboration between Montefiore Einstein
Comprehensive Cancer Center and the DRC’s National Cancer Program (CNLC). Using a mixed method
design, we will collect qualitative data from stakeholders and cancer patients to identify factors associated
with access to and adherence to cancer care and the economic burden of care for patients living with and
without HIV (Aim 1). We will use cognitive interviewing to adapt and validate widely used cost assessment
and quality of life tools for use in Kinshasa. We will use the adapted measures to survey 300 cancer
patients in Kinshasa to determine the financial burden of cancer care and assess its impact on completion
of cancer care cascade and quality of life (Aim 2). The results of this study can have a significant public
health impact in both the DRC and other low-income SSA countries with growing cancer incidence. CNLC
in close coordination with the DRC government is launching a major effort to scale up cancer care in the
DRC and establish new cancer centers. Our results will inform and strengthen this ongoing effort by
providing data to stakeholders to inform optimal design of care and better targeting for equity.
Title: Leveraging Existing Infrastructures and Expertise to Enhance Cancer Control in sub-Saharan
Africa
ABSTRACT
As part of the global socioeconomic transition, many low-and middle-income countries (LMICs) are
witnessing a shift in cancer profiles, influenced by the adoption of Westernized diets and lifestyles similar to
those seen in high-income nations. While high-income countries have robust cancer surveillance systems,
reliable cancer data is scarce in sub-Saharan Africa, hindering comprehensive understanding of the
disease burden and international comparisons. Population-based cancer registries (PBCRs) are crucial
tools for gathering this critical information. This supplement proposes to address this critical gap by
establishing PBCRs in the Democratic Republic of Congo (DRC), Burundi, and Cameroon. Leveraging our
existing infrastructure in these countries through CA-IeDEA and building on our proven expertise from a
successfully implemented cancer registry in Rwanda, this project seeks to fill this critical gap. These
registries will equip governments with crucial data for informed decision-making on cancer control and
enhance international collaboration, fostering knowledge exchange and contributing to global cancer
initiatives. Additionally, this supplement supports the primary aim of the parent grant to evaluate the
adverse clinical outcomes in people living with HIV (PWH), including the increasing cancer burden.
Currently, the lack of cancer tracking significantly limits our understanding of cancer diagnoses and the
overall burden of morbidity and mortality. Developing cancer registration in these three countries will
substantially improve our ability to measure cancer diagnoses and outcomes in CA-IeDEA.

Public health relevance
Title: Barriers and facilitators of cancer care and financial burden of cancer care in Kinshasa, the Democratic Republic of the Congo PROJECT NARRATIVE Growing cancer morbidity and mortality is a major public health problem in the Democratic Republic of Congo, yet there is lack of data on barriers to cancer care and its cost for cancer patients. This mixed- method study will identify factors associated with access to and adherence to cancer care and the economic burden of care for patients living with and without HIV. Title: Leveraging Existing Infrastructures and Expertise to Enhance Cancer Control in sub-Saharan Africa PROJECT NARRATIVE Sub-Saharan Africa faces a critical lack of reliable cancer data, despite a concerning shift in cancer profiles mirroring trends observed in high-income nations. This supplement seeks to address this significant gap by establishing cancer registries in the Democratic Republic of Congo, Burundi, and Cameroon. These registries will provide governments with essential data, crucial for informed decision-making in cancer control. Additionally, they will facilitate the tracking of adverse clinical outcomes in people living with HIV, a challenge with current data limitations.